Recruiting multiethnic populations to preclinical Alzheimers disease trials-Diversity Supplement

Abstract of Parent Research Project
Alzheimer’s disease (AD) and related dementias (ADRD) disproportionately affect underrepresented racial and
ethnic communities. The number of people with Alzheimer’s is expected to increase in the coming years, and
with this an increased burden to the public health system. To alleviate this, it is important to find treatments
through clinical trials that can slow disease progression, especially in diverse populations. Preclinical AD trials
lack diversity, and the trial requirements of learning one’s biomarker status and needing a study partner to enroll
could play a role. Our project focuses on understanding how the impact of these preclinical trial requirements,
biomarker disclosure and study partner requirement, differs among racial and ethnic groups. We will use
cognitive interviews to test our hypothesis that racial and ethnic groups differ in their willingness to learn
biomarker status. We will also use a previously developed assessment instrument1, to assess attitudes toward
the study partner requirement among diverse groups. We believe that the study partner requirement differentially
affects ability/willingness to participate among racial and ethnic groups. This work will help us collect data to
guide recruitment in preclinical AD trials in underrepresented groups, better understand attitudes toward
biomarker disclosure during the research process and understand the differences in attitudes toward the study
partner requirement so investigators can adjust to help underrepresented groups fill this role.

Public health relevance
Project Narrative Preclinical Alzheimer’s disease (AD) clinical trials enroll persons who have no observable cognitive impairment who demonstrate AD biomarkers. These trials require participants to learn their biomarker status and to enroll with a knowledgeable informant, or study partner, who also learns their biomarker status. Diversifying preclinical AD trial recruitment is an ethical and scientific imperative but faces daunting challenges. This proposal will elucidate potential racial and ethnic differences in barriers related to biomarker disclosure and the study partner requirement in preclinical AD trials.